CraniaMap: Joint Solution for Auto-Segmentation and Landmarking from CBCT Scans

SUMMARY / ABSTRACT: Cone beam computed tomography (CBCT) is revolutionizing medical diagnostics,
offering critical 3D insights for orthodontics, precise craniomaxillofacial (CMF) procedures, and comprehensive
reconstructive surgery plannings. Its pivotal role in implant planning and broad applications in neurosurgery and
oncology highlight its versatility too. However, the challenge lies in managing the vast 3D data for accurate
segmentation and landmark digitization (i.e., landmarking), which are crucial for treatment accuracy and
personalized patient care.
Our team at Ther-AI LLC is pioneering the development of the Crania software suite to tackle the complex
challenges of CBCT scan analysis. Our goal in this SBIR Phase-I proposal is to develop, CraniaMap, the
foundational module of the Crania software suite, that is engineered to dramatically enhance auto-segmentation
and landmarking in CBCT scans. This initiative is driven by the need for precision and efficiency in orthodontic,
CMF, and reconstructive surgery planning, where current artificial intelligence (AI) tools fall short. CraniaMap is
designed to excel where others falter, providing a robust, comprehensive solution that promises to enhance both
the speed and accuracy of these critical diagnostic processes.
In Aim 1, we will use our FuseNet segmentation tool to outperform existing models, particularly in handling
anatomical variations and pathologies. Our self-supervised learning approach, supported by solid preliminary
data, aims to achieve at least a 90% accuracy, as measured by the area under the curve (AUC), even in severe
cases, applied to 250 volumetric CBCT scans and the following tissues will be segmented: Cranial Bones (frontal
bone, parietal bones, temporal bones, occipital bone, sphenoid bone, ethmoid bone), Facial Bones (maxilla,
mandible, nasal bones, zygomatic bones, palatine bones, lacrimal bones, interior nasal concha, vomer), Orbit,
Teeth, and Airways. This represents a significant leap forward in medical imaging technology. Aim 2, automatic
landmarking, will harness the power of our advanced relational reasoning network (RRN) to pinpoint 105
essential anatomical landmarks with high precision. This innovative approach ensures accuracy even in complex
cases, with our goal being to maintain less than 2 mm mean square error across 250 diverse CBCT scans.
CraniaMap leads as the first integrated software to simultaneously offer segmentation and landmarking, and
it can even provide landmarks without the need for segmentation maps. This innovation is supported by our
years of experience in medical AI algorithms, and substantial preliminary data. CraniaMap will be a precursor
for several clinical applications spanning from orthodontics, CMF surgery and general dentistry. We expect that
CraniaMap to provide a standardized, efficient, and precise quantification landscape for cephalometric analysis
in the short term, and diagnosis, surgery/treatment planning, and outcome prediction in the long term. Millions
of patients who need CMF, reconstructive, or orthodontic operations will greatly benefit from CraniaMap.

Public health relevance
NARRATIVE Ther-AI LLC is proposing a pioneering software suite, called CraniaMap, to revolutionize CBCT scan analysis by enabling precise auto-segmentation and anatomical landmark digitization. This joint solution will significantly enhance orthodontic, craniofacial procedures, and reconstructive surgery applications, and deliver detailed anatomical maps with crucial anatomical landmarks that will standardize and refine patient care. We expect to achieve exceptional tissue, bone, and airway segmentation accuracy, surpassing existing models, and providing 105 landmarks on the fly for cephalometric analysis.